Single molecule study of C9ORF72 repeat RNA metabolisms in ALS/FTD

Amyotrophic lateral sclerosis (ALS), an adult-onset motor neuron degenerative disease, is increasingly
recognized to have clinical, pathological and genetic overlaps with Frontotemporal dementia (FTD). The
expansion of GGGGCC repeats in the first intron of C9ORF72 is the most common genetic cause of both ALS
and FTD. The disease has been predominantly attributed to the RNA repeats induced toxicity, including RNA
granules that sequester essential RNA binding proteins (RBP), and the toxic poly-dipeptides produced through
repeat-associated non-AUG (RAN) translation. Additionally, there is bi-directional transcription which leads to
formation of sense (GGGGCC)n and antisense (CCCCGG)n RNA foci in nuclei, as well as accumulation of five
different DPRs (poly-GA, poly-GR, poly-PA, poly-PR and poly-GP) translated from both strands in C9ORF72-
ALS/FTD patients. Understanding the repeat RNA metabolism is important for uncovering disease mechanisms
and identifying potential therapeutic targets. Combining the cutting-edge single molecule imaging approach with
biochemical and high-throughput sequencing assays, work from previous period systematically elucidated the
sense repeat RNA processing pathways and identified novel neurotoxicity mechanisms.
We now propose to apply similar technologies and platforms to determine the metabolism of antisense
repeat RNA and elucidate the relationships between sense and antisense RNA repeats. Recently, the clinical
trial of antisense oligonucleotide (ASO) targeting the sense repeat-containing RNA showed no neuroprotection,
and even indicated a faster decline in C9ORF72-ALS patients. While there could be various scenarios, one
plausible hypothesis is that the antisense repeat RNA also contributes to the disease pathogenesis, therefore
targeting sense repeats is not sufficient. Furthermore, the sense and antisense strands might affect each other’s
metabolisms and toxicity. Therefore, understanding the RNA metabolism of antisense repeats and how sense
and antisense RNAs influence each other will be crucial for developing effective therapeutic strategies. In this
proposal, we will explore the relationships between sense and antisense repeat RNAs, and assess how knocking
down one strand by ASO affects the RNA metabolism of the other strand. We will identify the antisense
(CCCCGG)n repeat RNA-associated proteins from intact cells, and determine its influence on cellular RNA
metabolism. Finally, we aim to identify genetic modifiers that can reduce the accumulation of both sense and
antisense repeat RNAs, thereby eliminating all possible gain-of-toxicity species from the repeat expansion.
Overall, this proposal tackles critical biological questions directly relevant to disease mechanisms that are largely
understudied in C9ORF72-ALS/FTD. The cutting-edge technologies provide opportunities to address the
mechanistic problems that are intractable by other techniques, potentially leading to new discoveries. The
findings from this study will provide valuable insights into the disease mechanism and therapy development.

Public health relevance
Repeat expansion in the C9ORF72 gene is the most common genetic cause of both amyotrophic lateral sclerosis (ALS) and Frontotemporal dementia (FTD), two adult-onset neurodegeneration diseases. Gain of toxicity from sense and antisense RNA repeats and poly-dipeptides plays an important role in disease mechanisms. We propose to investigate the repeat RNA metabolisms combining in vivo single molecule fluorescence imaging, biochemical and high-throughput screening approaches, which will help understand the etiology of the disease and develop therapeutic strategy.